Regulation of RNA condensates by RNA helicases in development

PROJECT ABSTRACT
RNA condensates, also known as membraneless organelles or RNA granules, are dynamic concentrations of
protein and RNA that spontaneously coalesce in the absence of a limiting membrane within the cytoplasm or
nucleoplasm through liquid-liquid phase separation. Eukaryotic cells harbor various RNA condensates,
including nucleoli, processing bodies, stress granules, and germ granules. Functioning as distinct states of
liquid, these droplets and their surrounding cytoplasm play a crucial role in concentrating reactants for cellular
organization and facilitating specific biochemical reactions during development. RNA, a critical component of
RNA granules, can promote or inhibit condensation, alter material properties and substructure organization,
and modulate interactions with surfaces. DEAD-box RNA helicases perform ATP-dependent RNA remodeling
activities and have been shown to regulate RNA condensates, but the mechanistic details connecting RNA,
RNA chaperones, and biological phenotype are largely unexplored. As interest in RNA condensates as an
organizing principle in the cell has grown, concerns regarding the evidence supporting their biological
significance have emerged. A key challenge for the field is developing technical approaches to measure and
manipulate condensates in biological systems and physiologically relevant biochemical reconstitutions. In this
proposal, we will investigate the regulation of germ granules, an RNA condensate implicated in germ cell
totipotency. Germ granules in C. elegans, have proven a valuable model for understanding RNA condensate
properties and biological functions. RNA helicases are critical and conserved regulators of germ granule
structure and function in animals including humans. The proposed research aims to establish a framework for
understanding the regulation of condensates by RNA helicases and the impact of condensation on RNA
helicase activity. To achieve these goals, we will combine analysis of condensates in an animal model with
biochemical reconstitution to investigate the molecular mechanics that underpin condensate regulation,
dynamics, and function in native cells. We will employ rigorous testing of emerging models through detailed in
vitro and quantitative cell-based assays using techniques including genome editing, condensate biophysical
measurements, quantitative super-resolution microscopy, and RNA biochemistry. This project uniquely
combines our multidisciplinary expertise to unravel fundamental cellular mechanisms and provide new insights
that will enable the identification of novel therapeutic targets for condensate-related diseases.

Public health relevance
PROJECT NARRATIVE RNA condensates have emerged as a fundamental mechanism for cellular organization and failure to properly maintain and regulate condensate properties is linked to human disease. This project will integrate developmental biology, RNA condensate biophysics, and RNA biochemistry to build a molecular framework to understand the regulation of RNA condensates during development. Completing this work, will shed light on the regulation of condensates in an animal model and provide insights into fundamental cellular mechanisms and new targets for developing therapeutic agents.